Parkinson's Disease Clinical Trial: Statistical Center

EXCEED THE SPACE PROVIDED. Medical University of South Carolina, Charleston, South Carolina Georgia Institute of Technology, Atlanta, Georgia Rush-Presbyterian-St. Luke's Medical Center, Chicago, IL University of Georgia, Augusta, Georgia